Immunobiology of Alloimmunization by Platelet Transfusion

Project Summary
Transfusion of platelets is a vital life-sustaining therapy for numerous diseases that result in thrombocytopenia.
However, platelet transfusion can also result in humoral alloimmunization, predominantly to human leukocyte
antigens (HLA). With immunization to multiple alloantigens, patients can become refractory to platelet
transfusion, resulting in difficulty supporting platelet transfusion needs, and in extreme cases can eliminate
platelets as a viable therapy, leading to morbidity and/or mortality from hemorrhage. Anti-HLA alloantibodies
can also be substantial barriers to transplantation, rendering patients ineligible for transplant in some cases, or
if they do get transplanted, leading to an increased kinetics and/or severity of rejection. Multigravid females
are particularly prone to alloimmunization – pregnancy appears to prime for subsequent alloimmunization to
platelet transfusion. Thus, alloimmunization to HLA is a significant problem in a number of settings. Although
leukoreduction of platelets has reduced rates of alloimmunization, residual immunity remains substantial.
Importantly, there are provocative data that distinct leukocyte subsets affect immunity differently (some
promoting immunity and others suppressing). Thus, the bulk removal of leukocytes may remove suppressing
(as well as immunizing) populations. A detailed understanding of the differential effects of distinct leukocyte
subsets would allow a more sophisticated engineering of platelet units with regards to selective modification of
leukocyte composition, if immunizing subsets can be removed and suppressing subsets retained. Such
information may also be of great utility in cellular therapies outside the context of platelet transfusion. This
proposal utilizes an innovative, novel, and tractable murine model, that allows a detailed dissection of the
relative contribution of different leukocyte subsets to alloimmunization. We have already used this platform to
make the observation that there is cooperativity between MHC alloantigens in inducing an immune response;
alloimmunization to the same alloantigen differs based upon the context of the mismatch, opening the door to
sophisticated matching/mismatching strategies for transfusion and transplantation in an era of personalized
medicine. We have also discovered that in mice, as in humans, pregnancy primes for a subsequent increased
alloimmune response rate to transfusion. We propose two specific aims, focusing on the cellular mechanisms
of alloimmune responses to different leukocyte subsets in naïve recipients and in pregnancy primed recipients,
respectively. We have built into this approach a further analysis of how context of mismatch alters
immunogenicity of a given alloantigen, to expand on our initial findings. The models generated for this
proposal use naturally occurring MHC alloantigens in mice, but focus on specific alloantigens for which cutting
edge tools are available to perform a detailed analysis of both alloreactive CD4+ T cell biology and
alloantibody generation. In aggregate, the proposed studies combine novel tools with innovative hypotheses to
ask mechanistic questions relevant to alloimmunization in the context of PLT transfusion and cellular therapies.

Public health relevance
Project Narrative Platelets are a type of blood cell that is required to stop people from bleeding. A number of diseases can lead to very low platelets, the only treatment for which is transfusing platelets from one person to another. However, when one person receives platelets from other person, the immune system can attack the donor platelets and eliminate transfusion as a viable therapy. This research proposal investigates the mechanism of this immune response with the goal of innovating new therapies to prevent the problem.